Mapping the neural and physiologic response to tonic pain with low-intensity focused ultrasound: a bridge towards therapeutic applications

PROJECT ABSTRACT
The experience of pain involves a combination of brain, autonomic, and behavioral responses, and dysfunction
in these neural and physiologic processes underlie several chronic pain conditions. How these systems interact
to generate the experience of pain, though, is poorly understood. The posterior insula (PI) and dorsal anterior
cingulate cortex (dACC) are core brain regions that serve critical functions in pain and autonomic processing,
however their causal role in these functions remain uncertain. The PI and dACC are thus promising therapeutic
targets for non-invasive neuromodulation, but unfortunately these regions are deep to the cortex, precluding
access with existing non-invasive techniques like transcranial magnetic stimulation (TMS) or transcranial
electrical stimulation (TES). Low-intensity focused ultrasound (LIFU) is an emerging non-invasive
neuromodulation approach that focuses mechanical energy to selectively target brain regions at any depth to
transiently and reversibly alter neural activity. The Legon lab was the first to demonstrate its potential for
neuromodulation in humans and has performed several foundational studies to establish LIFU’s potential as a
next-generation non-invasive technique. In this F30 proposal, we are mapping the neural and physiologic
responses to pain and then causally manipulating the PI and dACC to identify their specific contributions in these
processes in healthy participants. To accomplish this, we will leverage electroencephalogram and multimodal
physiologic measures including electrocardiogram, electrodermal activity, and continuous blood pressure
monitoring during a tonic, pain-inducing stimulus at various intensities. This work will help to determine key brain-
body interactions that subserve fundamental roles in the human pain experience.

Public health relevance
PROJECT NARRATIVE The experience of pain is a complex mixture of brain, autonomic, and behavioral responses, and the posterior insula (PI) and dorsal anterior cingulate (dACC) are key brain regions for pain and autonomic processing. Low- intensity focused ultrasound (LIFU) can safely, selectively, and non-invasively modulate deep brain regions, providing first-in-human capabilities for causally mapping the PI and dACC to better understand their function. This project will first leverage brain and multimodal autonomic measures during a tonic, pain-inducing stimulus to interrogate the neural and physiologic responses to pain and then use LIFU to map the causal role of the PI and dACC in these responses, laying the groundwork for future therapeutic interventions in chronic pain.